Enzymatic Synthesis of RNA

Enzymatic Synthesis of RNA
Foundation for Applied Molecular Evolution
Thomas Jefferson University
Steven Benner
Richard Pomerantz
ABSTRACT
The demand for synthetic RNA in biotechnology, research, and the clinic has increased dramatically in the
last few years. This is due inter alia to novel CRISPR-Cas9 genome engineering techniques, the re-invention of
aptamers and aptazymes with picomolar affinities using expanded genetic alphabets, and investigations of
small RNAs in mammalian biology, all relying on synthetic RNA. Even with some of the best firms advancing
classical phosphoramidite chemistry, 20 nmoles of an 120 nucleotide Ultramer® still costs $1080, a severe
limit on researchers asking "Why not?" and "What if?" questions using synthetic RNA.
The cost of RNA would be dramatically lowered if phosphoramidite chemistry were replaced by enzyme-
assisted RNA synthesis. Two advances make it now timely to achieve this "Grand Challenge".
Chemistry. The Benner lab invented a removable 3'-O aminoxy (ONH2) group for NextGen sequencing.
Now licensed to DNA Script in a "dual use mode" for enzyme-assisted DNA synthesis, aminoxies generate 200-
mers in good purity and yield. In a virtuous cycle, this led us to develop low cost solid-phase methods to make
aminoxy triphosphates at < $1/micromole, and methods to make 3'-O-aminoxy ribonucleoside triphosphates.
Enzymology. Marc Delarue (collaboration letter), DNA Script (collaboration letter), and Richard
Pomerantz (co-Investigator) discovered enzymes, including polymerase  and its variants, that add
ribonucleosides to an RNA primer. This creates an architecture for enzyme-assisted RNA synthesis based on
aminoxy termination that complements a classical architecture that exploits RNA ligase.
In Aim 1, we will use a classical architecture involving the ligation of nucleoside 3',5'-bisphosphates to learn
how to manage folding that occurs in natural RNA during enzyme-assisted synthesis. Even more than with
enzyme-assisted DNA synthesis, this folding obstructs the synthesis of a full range of RNA sequences. Novel
transformable, self-deprotecting, and soft deprotectable modifications should allow this problem to be resolve.
As Aim 2, we will engineer Pol  variants to find those that accept the 4 standard nucleotides in a Fig. 4.2
architecture that exploits 3'-ONH2 reversible terminators. These will be metricked by (i) rate of incorporation,
(ii) sequence independence of incorporation, and (iii) length dependence of these. The principal sources of
error (coupling failure leading to single nucleotide deletion) will be rigorously metricked
As Aim 3, we will implement a semi-automatic platform for RNA synthesis. We will also use ligases and Pol 
variants to incorporate "next generation" nucleotide analogs that have value in therapeutic RNA, RNA
aptamers and aptazymes, and RNA tagging. This will attract commercial instrument makers (e.g. DNA Script
and Nuclera were both contacted about this platform) to adapt their instrument to our chemistry/ enzymology.
Even before this happens, our semi-automatic platform will allow this technology to be transferred to NHGRI
centers that are chosen under NHGRI RFA-HG-20-019, a parallel RFA now accepting applications.

Public health relevance
Enzymatic Synthesis of RNA Foundation for Applied Molecular Evolution Thomas Jefferson University Steven Benner Richard Pomerantz Narrative Synthetic RNA is today used in biotechnology, research, and the clinic, as CRISPR-Cas9 genome engineering techniques emerge as tools central to biomedical research, aptamers and aptazymes with picomolar affinities and catalytic power emerge with expanded genetic alphabets, and investigations explore small RNAs in mammalian biology. However, for researchers asking "Why not?" and "What if?" questions using synthetic RNA, the costs are prohibitive, and the quality of synthetic RNA molecules is poor, especially when their length exceeds 60 nucleotides. The cost of RNA would be dramatically lowered by 10 fold if "chemical" methods were replaced by enzyme-assisted RNA synthesis, with the quality-length-cost metric likely enhanced 100 fold. This project will deliver this level of improved synthesis, from the laboratory that has been instrumental in creating enzyme-assisted DNA synthesis.